Grief and health-related quality of life in WTCHR Survivors: Associations with bereavement, trauma exposures, and mental and physical health conditions

Project Summary
Survivors of sudden and violent deaths, such as those that occurred on 9/11, are at higher risk for prolonged
grief disorder (PGD), in response to both that death and subsequent deaths. Despite World Trade Center
Health Registry (WTCHR) Survivors’ high rates of knowing someone who died on 9/11, there has been
minimal study of bereavement, trauma, and grief and their effects on health-related quality of life (HRQoL),
including cognitive functioning, in this population while accounting for the effects of gender, race, and ethnicity.
This proposal will first determine grief severity and the presence of self-reported threshold PGD in a
representative sample of English- and Spanish-speaking WTCHR Survivors. Study findings will provide a
greater understanding of grief severity/PGD among gender, ethnic, and racial groups and help to ensure that
public health efforts reflect the needs of the diverse WTCHR Survivor community.
This proposal will also examine the associations between bereavement and trauma with current grief severity,
including PGD. Using existing WTCHR data regarding 9/11-related bereavement and trauma and newly-
collected information pertaining to subsequent bereavement and trauma, as well as current grief, we will
examine the complex inter-relationships among these variables to outline pathways of risk. We will also
examine the impact of grief and these factors on HRQoL by determining how risk pathways and associations
described above (bereavement burden, trauma burden, grief severity/PGD) extend to HRQoL, while also
taking into account the effects of physical and mental health burden. As bereavement has been associated
with impairment in various cognitive functions that affect daily functioning which have also been associated
with quality of life, and cognitive impairments have been associated with WTC-exposure, we plan to assess
cognitive difficulties as an additional aspect of HRQoL. The last aim of this project addresses reports that
treatments for PTSD, depression, and anxiety disorder have not been readily available or accessed by
WTCHR participants. Therefore, we will determine the extent to which individuals who are at risk for PGD are
ready and able to access grief support within the community, and are satisfied with the support they receive.
This proposal brings together an experienced multidisciplinary team of collaborators from the Center for the
Study of Traumatic Stress at Uniformed Services University, the Center for Prolonged Grief at Columbia
University, the WTCHR, and Voices of September 11, Inc., which has an established history, familiarity, and
rapport with the 9/11 survivor community, as well as established working relationships with one another.

Public health relevance
Project Narrative Despite WTCHR Survivor’s high rates of 9-11-related and subsequent losses, minimal research has focused on the examination of grief responses (including the presence of PGD) and their effects on mental (including cognitive difficulties), social, environmental, and physical health-related quality of life (HRQoL) in this population while accounting for the effects of gender, race, and ethnicity. Using existing WTCHR data regarding 9/11 trauma burden and newly-collected information (regarding other traumas, bereavement burden, physical and mental health burden, grief severity, HRQoL, and cognitive difficulties), we will examine the complex inter-relationships among these variables to outline risk pathways in order to better inform WTCHP programming. We also intend to examine whether WTCHR Survivors at-risk for PGD have access to or would engage in grief-specific treatments, given that treatments for PTSD, depression, and anxiety disorders have not been engaged by all WTCHR participants.